Arousal-induced noradrenergic signaling modulates cortical astrocyte-neuron circuits during ethanol consumption

My career goal is to lead an independent research program studying astrocyte-neuron dynamics,
arousal, and alcohol use disorder (AUD). I have benefitted from experimental training in numerous
techniques including two-photon microscopy, neurophysiology, circuit anatomy, and behavior. During
the mentored phase of this grant (K99), I will continue to work closely with my co-mentors, Drs.
Mriganka Sur and Elena Vazey. Mriganka is an expert in cortical information processing, neuron-
astrocyte circuits, and optical techniques. Elena Vazey is an expert in noradrenergic signaling, stress,
alcohol-related behaviors, and chemogenetics. In addition, I will receive advice from my mentoring team
consisting of Drs. Kerry Ressler, Heather Richardson, and Thomas Kash. Their combined expertise
ranges across stress pathophysiology, alcohol-related processing, limbic and reward circuits,
neuromodulation, and anxiety behaviors. The additional training from my mentoring team will equip me
with the conceptual and technical acumen to become a significant contributor to the fields of alcohol
behavior and stress. This training will be done within the Brain and Cognitive Sciences department at
MIT, which provides both a vibrant intellectual research community and expansive research
infrastructure support. During my postdoctoral fellowship, I developed novel methods of simultaneously
imaging astrocyte-neuron networks to study astrocyte roles in information processing. This work led
me to study how astrocytes affect neuromodulation of cortical circuits by norepinephrine (NE). I have
found an intriguing astrocyte-neuron calcium signature that reflects a shift in cortical processing during
periods of high arousal. Furthermore, the drugs that are currently being tested in arousal disorders and
AUD block these signatures, suggesting that astrocyte-neuron interactions may provide crucial insight
into the pathophysiology of stress and AUD. My immediate goals are to understand how these events
relate to arousal and alcohol drinking behavior, and to determine the relationship with abnormal NE
release. (Aim 1) I will study the astrocyte-neuron processing in the prefrontal cortex (PFC) while mice
actively drink alcohol on using in vivo two-photon imaging. (Aim 2) I will determine the role of NE in
affecting astrocyte-neuron physiology through pharmacological and chemogenetic manipulations of NE
release. (Aim 3) Finally, during R00 phase, I will manipulate astrocyte-specific mechanisms to
determine the role of astrocytes in arousal-mediated alcohol consumption. These experiments will
clarify how astrocyte-neuron dysregulation in the PFC is related to NE release and AUD.

Public health relevance
Patients with disorders in arousal, such as post-traumatic stress disorder (PTSD), are particularly susceptible to developing alcohol use disorders (AUD). In this application, I will study the novel role of astrocyte-neuron networks in the prefrontal cortex and their modulation by arousal-induced noradrenergic release while mice actively drink alcohol. These longitudinal studies of the relationship between astrocyte-neuron dynamics and arousal during alcohol consumption will provide important information on arousal disorders, such as PTSD and AUD, and may provide clinical hallmarks or therapeutic avenues for the treatment of these disorders.